GENE MAPPING AND LINKAGE STUDIES WITH SHORT TANDEM REPEAT (STR) MARKERS

We are searching for genetic linkage between short tandem repeat (STR) markers and genes that contribute to the predisposition to alcoholism and related behaviors. This involves development of a battery of 200 highly polymorphic marker loci that span the human genome at approximately 10-15 centimorgan intervals. We are using florescent dye technology and constructing panels of 10-20 loci that can be run simultaneously in one gel lane. This will facilitate fast and accurate data collection. Computer programs are being written to interface between the gel analysis machinery and a statistical database. In addition, we are developing methods for PCR-STR optimization and for precise STR allele determinations. As more genotypes are collected in the next year, we will begin linkage analyses using sequential likelihood and affected relative pair methods. The informativeness of STR markers bestows new and heretofore unattainable power for establishing, and excluding, genetic linkage between definable chromosome segments and genetic vulnerability to disease.